Head Up CPR and Aortic Occlusion to Improve Survival after Refractory Cardiac Arrest

Abstract
In 2024 there will be nearly 800,000 cardiac arrest cases in the US alone. Of those only about 50,000 will have
a full recovery. More than 750,000 patients will have no hope for meaningful survival. That is because there is
no currently demonstrable effective treatment for refractory (R)-CA patients, the enormous subgroup of patients
who invariably die annually from this leading cause of death. Depending upon the presenting rhythm, CA
becomes refractory to current interventions, herein defined as a <2% survival, <10 minutes after starting
conventional (C) CPR. This application is focused on a better treatment for patients with CA refractory to current
management strategies, regardless of the initial rhythm presentation. Patients in R-CA cannot be resuscitated
with C-CPR, defibrillation for a shockable rhythm, and vasopressor therapy, such as epinephrine, fluids, and
anti-arrhythmic drugs. For over a half century we have failed to effectively treat R-CA: we have not known how.
Occasionally transcutaneous cardiac pacing, ECMO and/or double sequential defibrillation can be used with
some benefit for the very small percentage of patients that remain in refractory ventricular fibrillation (R-VF).
However, in general these treatment strategies rarely work for R-CA, especially in patients with a non-shockable
presenting rhythm that comprise 75-85% of all CA cases. However, the applicants recently observed that the
addition of resuscitative endovascular balloon occlusion of the aorta (REBOA) to automated Head Up Position
(AHUP) CPR resulted in a synergistic and remarkable improvement in coronary and cerebral perfusion pressures
after more than 30 minutes of AHUP-CPR in pigs. This discovery suggests that REBOA + AHUP CPR may
provide more definitive treatment for R-CA or, at a minimum, a bridge to more definitive therapy. Based upon
these new findings, the applicants intend to test the hypothesis that the addition of REBOA to AHUP-CPR for R-
CA will significantly improve brain and vital organ blood flow and increase the likelihood of neurologically-
favorable survival in a well-established pre-clinical model.

Public health relevance
Project Narrative The overall goal of this application is to improve neurologically-intact survival rates after sudden cardiac arrest. In the US alone, SCA kills more than 400,000 individuals outside the hospital and an equal number inside the hospital annually. Phase 1 funding will support the evaluation of a novel CPR method to treat refractory cardiac arrest that includes resuscitative endovascular balloon occlusion of the aorta in combination with automated controlled sequential elevation of the head and thorax. These advances have the potential to increase survival with favorable neurological function in victims of sudden cardiac arrest.